Voltage-Gated Calcium Channels in Nociceptors and Mechanoreceptors

Voltage-gated calcium ion channels are critically important proteins that regulate release of glutamate and
substance P from nociceptors in the superficial dorsal horn of the spinal cord. As such, they serve as the
gatekeepers, at the junction of the periphery and central nervous system, conveying information about touch,
heat, mechanical stimulation and more to the brain. High heat or strong mechanical stimuli are noxious and
perceived in the brain as painful. Neurons that detect potentially harmful signals, such as high heat, are
essential for protecting the body against damage. In response to continued stimulation, such as occurs in
tissue injury, these neurons can sensitize as part of a protective response, but their sensitivity usually returns
to normal after healing. In certain chronic pain conditions, such as after peripheral nerve injury, the sensitivity
of nociceptors fails to return to pre injury levels and normal heat and touch continue to be perceived as painful.
This persistence of sensitization combined with ongoing spontaneous activity of pain circuits can result in
unrelenting, chronic pain. Understanding the molecular and cellular changes that occur during the transition
from normal to chronic pain states are the key to improving current – inadequate – therapies. This proposal
builds on our recent discoveries and our unique expertise to determine the role of voltage-gated calcium ion
channels in sensory neurons that contribute to chronic pain. We study Cacna1a and Cacna1b genes that
encode the core subunits of two calcium ion channels, CaV2.1 and CaV2.2, that control transmitter release at
the majority of synapses in the mammalian nervous system. We tackle two critically important questions in our
overall objective to elucidate the molecular mechanisms that orchestrate Cacna1a and Cacna1b processing
and their actions in different subtypes of sensory neurons that transmit information about thermal and
mechanical stimuli: Aim 1. What cellular factors control the expression of the major forms of CaV2 channels in
thermal and mechanical signaling? What molecular changes disrupt the normal pattern of expression of these
calcium ion channels in chronic pain? Aim 2. How do different calcium ion channels function in thermal and
mechanical signaling at peripheral nerve endings in skin? And do the abnormal expression patterns of different
forms of ion channels contribute to the induction and maintenance of abnormal signaling? Our research
addresses major gaps in our understanding, and the results will contribute to new strategies and reveal new
targets for pharmacological or genetic approaches, to mitigate certain forms of chronic pain experienced by
millions of people in the United States.

Public health relevance
Voltage-gated calcium ion channels are the gatekeepers that sit at the junction of the peripheral and central nervous systems. Our research is focused on the importance of these channels in normal and abnormal pain. We hope to generate new strategies to mitigate some forms of chronic pain experienced by millions of people.